Transcriptional control of proteostasis and aging

Project Summary/Abstract:
The mechanisms that maintain proteome folding and function (proteostasis), become ineffective during normal
aging, contributing to the onset and progression of neurodegenerative protein misfolding diseases- including
Alzheimer’s Disease. Proteostasis is sustained through integrated processes involving coordinated regulation of
protein synthesis, folding, and degradation in response to diverse signals. We have identified the homeodomain-
interacting protein kinase (HPK-1) as a key regulator of aging and proteostasis. Constitutive expression of hpk-
1, is sufficient to delay aging, preserve proteostasis, and promote stress resistance, while loss of hpk-1 impairs
stress resistance, accelerating aging and the deterioration of the proteome. HPK-1 acts via the heat shock
transcription factor (HSF-1), and the target of rapamycin complex 1 (TORC1). HPK-1 antagonizes sumoylation
of HSF-1, presumably to repress gene expression. HPK-1 extends longevity by an additional independent
mechanism: induction of autophagy via dietary restriction or TORC1 inactivation. HPK-1 expression is itself
regulated by distinct mechanisms after nutritional or thermal stress, implying that HPK-1 may function as part of
an integrated stress response to maintain proteostasis. Notably, we also have found that hpk-1 is required for
maintaining proteostasis in C. elegans neurons, and a recent study found induced expression of a mammalian
homolog in regions of the brain affected by neurodegeneration in Alzheimer’s Disease and Amyotrophic Lateral
Sclerosis patients, suggesting an induced stress response. Our hypothesis is that HPK-1 prevents the age-
associated decline of proteostasis by suppressing protein misfolding and stimulating protein turnover through
the regulated gene expression of chaperones and autophagy, respectively. We will gain mechanistic insight into
how HPK-1 regulates HSF-1 and affects aging and proteostasis through the use of proteomics and
CRISPR/Cas9 targeted mutagenesis. We will apply combinations of stressors and activated HPK-1 to
understand how HPK-1 functions as a part of an integrated system to maintain proteome function. We utilize
genetic, genomic, and systems biology approaches to explore how dynamic regulation of the proteostatic
network safeguards proper function of the proteome. In addition, we will employ tissue-specific gene
manipulation to understand how this network acts across tissues. To determine the physiological consequences
of hpk-1 on neuronal proteostasis and degeneration we will utilize a polyglutamine reporter and isoforms of tau
to induce proteotoxicity within C. elegans neurons. Additionally, we will determine the role of Hipk1-3 loss
(mammalian homologs of hpk-1) in the context of pharmacological interventions targeted to reduce proteotoxic
effects of tau in mammalian neurons. With this work we will gain understanding of the role of HPK-1 during aging
in the regulation of the proteostatic network, and insight into the manifestation of neurodegenerative diseases.

Public health relevance
Project Narrative: Our work will establish how the transcriptional co-factor HPK-1, regulates the proteostatic network and maintains proteome integrity during aging. Understanding mechanisms capable of preserving proteostasis will facilitate development of rational strategies for the treatment of wide-spread protein misfolding diseases, such as Alzheimer’s Disease and improve healthy aging.